Stem Cells for Neonatal Hypoxic-Ischemic Brain Injury

PROJECT SUMMARY/ABSTRACT The specific objective of this STTR Phase II research and development project is to provide an optimized cellular therapy regimen for treating hypoxic-ischemic (HI) injury and its related outcomes in neonates. Pre- clinical studies performed in a rat pup model of HI injury as part of the funded Phase I STTR grant, point to benefit when Multipotent Adult Progenitor Cells (MAPC), a pluripotent adult stem cell, are administered intravenously (IV) or intracerebrally (IC) one week post-HI injury. Syngeneic and allogeneic MAPC demonstrated statistically significant efficacy in the absence or presence of immunosuppression, thereby resolving key clinical issues for using MAPC as an [unreadable]off-the-shelf[unreadable]allogeneic product. After receiving feedback from the FDA following a Type B pre-IND discussion, this Phase II proposal aggressively pursues those preclinical issues required to advance the application of MAPC based therapy to treat HI injury in neonates. This Phase II STTR submission has 4 specific aims, which will complete the pre-clinical report package required for IND submission. Aim 1: Determine that the anticipated clinical product, human MAPC processed under cGMP conditions, exhibits therapeutic behavioral and histological benefit equivalent to those previously observed with allogeneic rat MAPC in the rat neonatal HI injury model. Dosing experiments will include: Aim 1.1: IV dose ranging to determine optimal dose of human MAPC;Aim 1.2: Optimal timing of delivery, post-HI injury; and Aim 1.3: Benefit of multiple IV dose administrations. Aim 2: Demonstrate stable and long-term therapeutic behavioral and histological benefits of MAPC grafts in the rat HI injury model, i.e., 6 months post-transplantation with safety component in both male and female neonatal rats, using optimized conditions from Aim 1 (as per FDA recommendation). Aim 3: Determine the relative efficacy benefit of cell therapy in minimal, moderate and severe HI injury models. These data will help determine the appropriate inclusion criteria and clinical endpoints for Phase I and Phase II clinical development (as per discussion with FDA). Aim 4: Characterize stem cell histocompatibility, inflammation and tumor/ectopic tissue formation in rat and human MAPC to support safety of IV MAPC in rat neonatal HI model. The overarching goal of this STTR Phase II study is to provide the optimal regimen of MAPC transplantation in an HI model that addresses the feasibility, safety and efficacy criteria within the standards of FDA regulations, thereby realizing a smooth translation of this cell based therapy from the laboratory to the clinic. PROJECT NARRATIVE The treatment of hypoxic-ischemic (HI) brain injury in newborns and young children is an unmet medical need in the United States. The incidence and effects of HI brain injury in children are complex, but the number of patients affected is large by any assessment, with a frequency of 1 in 4000 live births (1), and with neonatal encephalopathies due to all causes occuring in 1 to 6 out of every 1000 births (2). More than 95 % of these infants survive with considerable cognitive and motor deficits (3), and although cell-based therapies have emerged as experimental treatments for a number of other neurological and cardiovascular disorders, there is currently no treatment for HI injury other than post-injury supportive care. The specific objective of this research project is to develop an optimized cellular therapy regimen for treating HI injury in neonates.